Assessment of biological &social risk in pre-term infants

The purposes of this study are to compare the effectiveness and clinical utility of 4 indices of biological risk in predicting the developmental and health outcomes of premature infants and to examine how these measures interact with social risks. The ultimate goal of this study is to identify a parsimonious set of predictors that could be used clinically to identify infants in need of intervention. Early intervention services could then be targeted to infants most likely to benefit from them. Specific research questions to be addressed are: effectiveness of 4 indices of biological risk--sleeping and waking state maturation, EEG dysmaturity, neurological insults (NBRS), and visual recognition memory--in predicting 9- and 27-month health and developmental outcomes of premature infants; identify the relationship between the indices of biologic risk; interaction of the biological risk indices with social risk indice (overall quality of the environment and mother-infant interactions) in predicting 9- and 27-month developmental and health outcome of prematures; and the identification of effective prediction equations for developmental and health outcomes. Sixty-five high-risk preterm infants at this site and 65 from UNC Hospitals will be recruited as soon as their medical conditions are no longer critical and will be followed until 2 years past term. During the preterm period, 2-hour state observations and respiration recordings will be conducted weekly up to 8 times and repeated at 1-month post-term. This data will be used to determine the developmental trajectories of sleep-wake states and related behaviors. EEGs will be conducted during the second, fourth, and eighth observations and at the 1-month follow-up visit. Visual attention measures will be obtained at 2, 6, and 9 months. Home visits will be made at 6 and 18 months to score the HOME Inventory and videotape mother-infant interactions. Outcome measures will be the Bayley II at 9 and 27 months, a language test at 27 months, infant growth parameters throughout the first 2 years, and the health problems experienced by age 2. Data analysis will concentrate on determining similarities and differences in the biological risk indices, determining the degree to which biological and social risks interact to predict outcome, identifying a prediction equation for each outcome, and determining the sensitivity and specificity of these equations.